Strength-Based Health Equity Across the Life Course

Increasing diversity coupled with a growing concern over persistent health inequities in the U.S. requires
nurse scientists to pay closer attention to factors operating at the social/environmental, behavioral/
psychological, and biological levels while harnessing big data and evidence-based practices through an equity
lens. In particular, participatory research that builds on strengths and resources within the community is a
transformative implementation research paradigm by bridging the gap between science and practice through
meaningful stakeholder engagement and social action to promote health equity. This T32 application is
requesting 5 years of funding to support a predoctoral research training program that aims to prepare nurse
scientists to lead rigorous, innovative research that drives improvements in health equity in disadvantaged
populations across the life course. Building on the Commission on Social Determinants of Health framework
and population health equity framework, trainees will engage in a series of structured curriculum and mentored
research experiences to focus their research skill development in the following four thematic cores: stakeholder
engagement methods, biologic and social measurement, data science, and intervention and implementation
science. These methodologic advancements are crucial to adequately characterize the nature of inequities in
healthcare and to develop more effective and sustainable strategies to promote health equity. We have
assembled an exceptional constellation of program faculty and mentors from the Schools of Nursing, Medicine,
and Public Health who lead interdisciplinary training and health equity research programs that have
significantly enhanced our understanding of health inequities and approaches to health equity in
disadvantaged populations. Their collective health equity research portfolios provide an impressive variety of
resources in a rich interdisciplinary training environment and training opportunities in stakeholder engagement
methods, biological and socio-behavioral measurement, data science, and intervention and implementation
science. The two-year training program will recruit four nurses at the predoctoral level each year. Training a
new generation of interdisciplinary nurse scientists with strong knowledge and skills in stakeholder
engagement, measurement, and methodological approaches will further advance our ability to address the
complex nature of health inequities experienced by disadvantaged populations in the nation.

Public health relevance
Compelling evidence exists that vulnerable populations such as people of color, persons of lower socioeconomic status, or individuals with limited health literacy continue to have significant health problems. We are proposing to train nurse scientists who can address these problems in new and effective ways which in turn will promote health equity.